Elucidate the role of higher-order chromatin organization during terminal differentiation in mouse erythropoiesis

Project Summary:
It is widely appreciated that erythropoiesis serves as an excellent model for studying
modifications in chromatin organization and resultant gene expression patterns within identical
cells. This process involves significant chromatin reshuffling and a loss of topologically
associating domains, ultimately leading to global transcriptional silencing upon terminal erythroid
differentiation. Despite these insights, the precise structural changes underpinning the distinct
gene expression seen in terminally differentiated erythroid cells remain enigmatic. Therefore,
there is an urgent need to elucidate the detailed molecular mechanisms governing chromatin
architecture modifications during erythroid terminal differentiation, to enhance our understanding
of erythropoiesis-related diseases, particularly anemia.
The
overall objective of the proposed research is to decipher the roles and interactions of
erythroid-specific transcription factors and chromatin structural proteins during erythropoiesis,
defining how they lead from cellular expansion to differentiation. Our
central hypothesis posits
that erythroid-specific transcription factors and architectural proteins direct modifications in
chromatin organization integral to erythroid terminal differentiation. To this end the specific aims
of this proposal seek to combine functional studies with state-of-the-art-multi-omics approaches
to:
1) Test the functional role of architectural proteins during terminal differentiation in mouse
erythropoiesis
2) Identify and characterize chromatin re-organization events during terminal differentiation
3) Identifying the molecular mechanisms underlying the 3D chromatin changes during
erythropoiesis

Public health relevance
Project Narrative: The long-term goal of this project is to enhance our understanding of the dynamic interplay between chromatin organization and terminal differentiation during erythropoiesis, which will help in the comprehensive understanding of diseases stemming from abnormally differentiated erythroid cells, that can lead to anemia, thus, paving the way for therapeutic advancements.